Center for Redox Biology and Cardiovascular Disease

Project Abstract
Cardiovascular disease is the leading cause of death and disability in the United States with a disproportional
effect on southern regions of the country. According to the 2016 America's Health Rankings Annual Report,
Louisiana ranks 46/50 in cardiovascular deaths and 48/50 in heart disease placing it in the lowest categories of
cardiovascular health across the nation. Moreover, for the first time in 27 years, the rate of cardiovascular
deaths increased across the nation highlighting the magnitude and importance of cardiovascular research.
While advances in cardiovascular treatments have been realized, many cardiovascular disease mechanisms
remain poorly understood. It has become clear that changes in heart and vascular oxidative stress and
antioxidant defenses, the so called `redox balance', plays critical roles in disease initiation and propagation.
However, specific ways that alterations in redox biology control cellular and molecular responses leading to
cardiovascular disease remains largely unknown. The Center for Cardiovascular Diseases and Sciences at
LSU Health Sciences Center Shreveport has assembled investigators with state of the art knowledge and
research expertise across several departments to address redox biology molecular mechanisms contributing to
cardiovascular pathophysiology. The intent of this proposal is to develop and establish a COBRE Center for
Redox Biology and Cardiovascular Disease with a nationally recognized enriched training environment for
junior faculty that advances the competitiveness of research programs for national awards. Individual primary
projects have been carefully chosen based on their relevance to the research theme, novelty of the research
topic regarding redox biology and cardiovascular disease, and their potential ability to achieve program
independence. The proposed projects will provide new understanding of redox biology mechanisms required
for cardiac and vascular (dys)function with support from advanced, state of the art animal models and redox
molecular pathology research core facilities. Research and professional development programs are also
proposed that will provide continued growth and leadership in this area.

Public health relevance
Project Narrative The COBRE Center for Redox Biology and Cardiovascular Disease will provide a unique training and research environment for investigators to receive mentorship and guidance, while increasing the competitiveness of their research program for national funding. The Center will advance new insights and understanding of redox biology control of heart and vascular disease processes that may lead to new and better ways to detect or treat cardiovascular disease.